Histologic and Transcriptional Profiling of Endothelial Cells During Progressive Pulmonary Fibrosis

PROJECT SUMMARY
Idiopathic Pulmonary Fibrosis (IPF) is a progressive scarring lung disease that very often leads
to respiratory failure. There remains a large unmet need for effective therapies. IPF is thought to
be driven by injury to a vulnerable epithelium, sensitive to dysfunction either by genetic
mutations or by the dose or type of injury. Epithelial dysfunction and senescence lead to diffuse
tissue injury and activation of myofibroblasts. Dysregulated wound repair mechanisms may play
a role in amplification of the tissue injury, tipping the balance from repair to fibrosis. Data is
emerging that there are abnormalities in the pulmonary endothelium of patients who develop
pulmonary fibrosis, although the cause/effect of these changes on the process of fibrogenesis is
not well understood. Increased vascular permeability has been shown in the lungs of IPF
patients and predicts mortality. In addition, several recent single-cell RNA sequencing studies
have demonstrated loss of pulmonary capillaries and an increase in a bronchial vessel
population. The full mechanistic implications of these changes have not been defined.
Rho-associated kinase (ROCK) signaling has been shown to play a major role in several
endothelial cell functions, including cell contractility and subsequent alterations in vascular
permeability. I have shown in preliminary data that loss of ROCK2 specifically in endothelial
cells in a mouse model (EC ROCK2 KO) prevents the development of pulmonary fibrosis
induced by the delivery of intratracheal bleomycin. In addition to less pulmonary fibrosis, these
mice had less vascular permeability in the early time period after bleomycin, before fibrosis
develops. This finding suggests a link between endothelial ROCK2, vascular function, and
pulmonary fibrosis, and hints at the potential for an opportunity for early intervention, when
fibrosis may be preventable or reversible.
In this current proposal, I propose to explore the protective phenotype in EC ROCK2 KO
mice further by using these mice in a repetitive bleomycin model of pulmonary fibrosis, which
has been shown to produce progressive fibrosis and is more similar to IPF. I will characterize
the endothelial changes in this repetitive bleomycin model through staining and permeability
assays. I will also perform single-cell RNA sequencing of mouse lungs with or without ROCK2,
in the repetitive bleomycin model of pulmonary fibrosis. I will look for mechanistic links between
endothelial ROCK2 and angiogenesis, senescence, endothelial to mesenchymal transition and
apoptosis, all in the context of fibrogenesis.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis is a progressive, fatal disease associated with endothelial dysfunction, including increased pulmonary vascular permeability. This project will define the connection between endothelial ROCK2 signaling, vascular permeability and pulmonary fibrosis through immunofluorescence staining and transcriptional profiling. Our results will identify new therapeutic targets to halt or ideally reverse the relentless progression of this disease.